Administrative supplement to purchase a sequencing equipment

Administrative supplement to purchase sequencing equipment
Parent award: R01GM098642
Evolutionary dynamics of combinational antimicrobial treatments
Abstract
Due to over-prescription and misuse, antibiotics are losing their efficacy due to emergence
and rapid rise of antibiotic-resistant bacteria. Of different types of antibiotics, β-lactams
have been prescribed to treat the majority of infections since the discovery of penicillin.
Since then, bacterial resistance to β-lactams, mediated by the production of extended
spectrum β-lactamase (ESBL) enzymes, has become widespread. Using β-lactamase
(Bla) inhibitors can restore the efficacy of β-lactams against resistant bacteria, a strategy
which is necessary to preserve existing antibiotics in the face of declining investment in
new antibiotics. However, the effect of combination treatment on selection for β-lactam
resistance is not well understood. Our proposed research in the parent award will examine
these evolutionary dynamics in depth using a combination of mathematical modeling and
quantitative experiments. In this Administrative Supplement grant, we propose to
purchase an Illumina MiniSeq Sequencing System, which will be used to facilitate the
measurements proposed in the parent award.

Public health relevance
Relevance to Public Health The relevance of the Administrative Supplement grant is tied to its parent award, which will provide mechanistic insights into the evolutionary dynamics arising from the combination treatment of resistant bacteria. These insights will guide the design of effective treatment strategies that can extend the shelf-life of existing antibiotics.